Reducing Alcohol Use among Black Men: Barbershop SBIRT

SUMMARY – PROJECT 3
Unhealthy drinking is considered one of the top 10 public health concerns in the United States.1 Not only has
heavy drinking been linked to poorer overall health, it is responsible for about 88,000 deaths and 2.5 million
years of potential life lost in the United States each year.2 Men exposed to social disadvantage, such as Black
men living in poverty, are more likely to consume more alcohol.3–5 Indeed, in Arkansas, a state with high rates
of unhealthy drinking, Black men who make less than $35,000 are more likely to report heavy drinking
(4 or more drinks a day) and consume more drinks when binge drinking.6 Further, the negative impacts of
unhealthy drinking may be worse for Black men. Black men who report consuming large amounts of alcohol
often experience more severe health outcomes and more negative social consequences when compared to
other ethnic groups.7–11 Screening, Brief Intervention, and Referral to Treatment (SBIRT) is an evidence-based,
multilevel, integrated, public health approach to the delivery of early intervention services for individuals at risk
for risky drinking, and the timely referral to more intensive treatment for those who have substance abuse
disorders.12–14 SBIRTs have been effectively implemented in both primary care and emergency care settings15.
However, structural barriers to care (i.e., insurance status, culturally competent services, racism and
discrimination, etc.) may impede Black men's access to evidence-based care for unhealthy drinking
located in medical settings.16 Given the increased risk for mortality and morbidity associated with unhealthy
drinking among Black men living in poverty, coupled with the more harmful health consequences of unhealthy
drinking for Black men, improving equitable access to evidence-based care by implementing care into community
settings that Black men are more likely to access is urgently needed.
Thus, the goals of this proposed Hybrid Type 2 pragmatic effectiveness-implementation trial are to: 1) test the
effectiveness of a previously developed, evidence-based SBIRT intervention (Barbershop Talk) for low income
African American men; and 2) generate the scientific evidence needed to disseminate SBIRTs to “real world”
settings. Data from this study will further our understanding on how to reduce the risk of alcohol attributable
morbidity and mortality among Black men living in poverty. Data will also improve our understanding of strategies
that can improve implementation of evidence-based care models in non-clinical settings; thus, extending the
reach of evidence-based care to communities with the highest need.